09 Breast Cancer Research Program

BREAST CANCER RESEARCH PROGRAM (BCRP): PROJECT SUMMARY
The long-term goals of the Breast Cancer Research Program (BCRP) are to define the
fundamental mechanisms that regulate breast cancer pathology and then use this information to
develop personalized strategies for the prevention, diagnosis, and treatment of all stages and
subtypes of breast cancer. The BCRP leadership established collaborative working groups in
clinical, basic, and population sciences to identify and develop novel implementation strategies
for the diagnosis and treatment of breast cancer. These three groups are guided by the
hypothesis that advances in basic and population sciences can be leveraged to enhance the
clinical impact in successfully treating breast cancer. These translational efforts have been
organized around three specific aims. Aim 1. Discover, identify, and validate novel personalized
clinical targets for breast cancer. Aim 2. Utilize institutional expertise in basic sciences to define
the molecular mechanisms that drive breast cancer progression and metastasis in individuals.
Aim 3. Equalize breast cancer mortality by identifying personalized risk factors and developing
targeted prevention and genomic strategies. The BCRP contains 19 members from four
departments and two schools. Current funding exceeds $7.9 million, with $3.0 million from the
NCI and $1.8 million from other peer-reviewed funding. BCRP members published 456 papers
during 2014-2018, with 42% inter-programmatic publications and 24% intra-programmatic
publications; that included contributions to Cell, Nature, Nature Communications, Nature
Genetics, Cell Reports, Journal of Clinical Investigation, Journal of Clinical Oncology, and Journal
of the National Cancer Institute. The broad-ranging achievements and future objectives of the
BCRP cross the translational spectrum from basic science research to clinical and translational
research.